IMPROVING ANIMAL RESOURCES FOR BIOMEDICAL RESEARCH

Our objectives are to promote excellence in biomedical research through development and maintainance of high quality animal resources. To meet these objectives we propose three major projects within the animal resources program: 1. Renovate animal surgery facilities to provide a suitable environment for recovery surgery and meet DHHS guidelines. 2. Improve satellite animal housing facilities to meet DHHS guidelines. (No funds are requested for this project.) 3. Improve the central animal facilities to provide better utilization of space and meet the needs of the research faculty by upgrading animal housing and procedural areas. These improvements will benefit animal research projects totalling approximately $22 million, and will add to the substantial improvements the College has already made to upgrade animal resources, which have cost more than $5 million over the last two years.